DCP - Clin Trl Info Mgt -DCP Enterprise System Knowledge Base (DESK)

The Contractor shall provide basic and translational research and research support to NCI DCP. Areas of research and research support may include primary and secondary cancer prevention. Examples of support activities may include research, technical support, laboratory management, administrative support, and project management.